Stanford Alzheimer's Disease Research Center

1. SUMMARY (Overall)
The National Alzheimer's Project Act establishes an integrated national plan to overcome Alzheimer's disease
(AD); develop treatments to prevent, halt, or reverse the course of AD; improve the early diagnosis of AD; and
decrease disparities in AD for ethnic and racial minority populations at higher risk for AD. In this context, AD is
intended to encompass AD-related dementias, including dementia with Lewy bodies. In support of the goals
and research milestones of the National Alzheimer's Project Act, the mission of the Stanford Alzheimer's
Disease Research Center (ADRC) is to serve as a shared resource to facilitate and enhance research on AD
and the spectrum of cognitive impairment associated with Lewy body (LB) pathology. We follow a strategy of
deep phenotyping, believing that critical answers emerge more readily when investigators are able to delve
deeply within and across multiple levels of participant data. Healthy adults without cognitive or motor
impairment serve both as a comparison (control) population and as a preclinical population in which
mechanisms of cognitive aging and clinical transition can be studied. People with Parkinson's disease without
cognitive impairment also serve as comparators and as an at-risk transitional population for the development of
cognitive impairment linked to LB pathology. ADRC resources will provide investigators with unique
opportunities for the parallel study of these two neurodegenerative disorders, enabling insights into
pathogenesis, preclinical diagnosis, transitions, resistance and resilience, and therapeutic approaches. Aims of
the Stanford ADRC are to (1) provide an administrative structure that advances the mission of the center; (2)
develop and maintain human resources for studies of the AD spectrum and the LB spectrum of cognitive
impairment, as well as cognitive aging; (3) make available well-characterized brain tissues, brain-derived
biospecimens, and quantitative molecular data derived from high-content imaging of brain tissues; (4) make
available participant biospecimens and high-content biospecimen data; (5) provide structural, functional, and
molecular neuroimaging biomarkers in support of research on AD-spectrum cognitive impairment, LB-spectrum
cognitive impairment, and cognitive aging; (6) provide for the management of Stanford ADRC data, prepare
research datasets, provide high-level biostatistical consultation for ADRC investigators, and support research
on big data using tools from biostatistics, bioinformatics, and artificial intelligence; (7) with our community
partners, provide respectful, culturally sensitive outreach and provide opportunities for education, training, and
research participation for healthy adults, people with AD-spectrum and LB-spectrum disorders, and their
families. Stanford ADRC outreach and community engagement extends particularly to urban Hispanic/Latino
older adults, an important Bay Area population, which is under-represented in AD-related research; and (8)
support the training of investigators and future leaders in the field of AD and related dementia.

Public health relevance
PROJECT NARRATIVE (Overall) The Stanford Alzheimer's Disease Research Center supports the National Alzheimer's Project Act by serving as a shared resource to promote research on Alzheimer's disease, cognitive impairment linked to Lewy body changes in the brain, and cognitive aging.